LiveWell: An Adapted Dialectical Behavioral Therapy Skills Training Protocol for Patients Living with Metastatic Lung Cancer

Patients are living longer with metastatic lung cancer (i.e., metavivors) due to therapeutic advances, but face
significant challenges. Most metavivors will ultimately die of cancer and must navigate the duality of living while
dying. Unsurprisingly, metavivors endorse high psychological distress (e.g., anxiety, depression, illness non-
acceptance), high symptom burden (e.g., fatigue, dyspnea, pain), and poor quality of life. Psychosocial
interventions can improve outcomes, but existing paradigms are not designed to help metavivors navigate the
emotional turbulence of living with metastatic disease. Dialectical Behavioral Therapy (DBT) Skills Training is an
evidence-based treatment that teaches patients transdiagnostic, easy-to-use skills to both accept things as they
are (mindfulness, distress tolerance) and change things within their control (emotion regulation, interpersonal
effectiveness) to better navigate life challenges. However, DBT Skills Training has rarely been applied in patients
with chronic illness. We adapted DBT Skills Training (e.g., intervention dose, delivery, content) for patients living
with metastatic lung cancer to create LiveWell, an 8-session Skills Training protocol delivered one-on-one via
videoconference. Building on preliminary data and aligned with the ORBIT model for behavioral intervention
development, the first phase of this study (K99, Aim 1, 1 year) aims to iteratively refine LiveWell using 1)
qualitative exit interview data from a proof-of-concept study, 2) an advisory board of interested parties, 3) the
Dynamic Sustainability Framework from implementation science, and 4) user testing (n=10). The K99 phase will
produce a standardized protocol and procedures for the R00. The second, independent phase of the study (R00,
Aim 2, 3 years) will be a Phase IIB randomized pilot trial to test study feasibility, acceptability and outcome
patterns suggesting the efficacy of LiveWell compared to Enhanced Usual Care (EUC). Lung cancer metavivors
(n=80, >20% non-White) receiving care at NCI-designated centers (N=2 sites) and endorsing distress >3/10 will
be randomized to LiveWell or EUC. We hypothesize that: 1) LiveWell and EUC protocols and procedures will
show evidence of feasibility (accrual N=80/20 months, >80% adherence to interventions and assessments,
<20% attrition) and acceptability (>3/5 satisfaction study procedures, >3 mean intervention satisfaction
LiveWell)), and 2) LiveWell will improve quality of life (primary outcome) and reduce psychological distress
(depression, anxiety, illness acceptance) and symptom burden (fatigue, dyspnea, pain) (secondary outcomes)
from baseline to post-treatment compared to EUC. We will explore emotion regulation as a mechanism of
change. The objective of this Early K99/R00 is to provide Dr. Hyland with limited additional mentored training,
then facilitate her transition to an independent investigator working to develop, test, and implement novel
psychosocial interventions for cancer metavivors. Findings from this study will inform an R01 submission to
conduct a Phase III efficacy trial of LiveWell. If successful, LiveWell will improve metavivor quality of life and
provide a promising psychosocial intervention paradigm for other metavivors and patients with chronic illness.

Public health relevance
Project Narrative. Patients with metastatic lung cancer are living longer (i.e., metavivors), but they experience high psychological distress (i.e., depressive symptoms, anxiety, illness non-acceptance), persistent symptom burden (i.e., fatigue, dyspnea, pain), and poor overall quality of life. Given that existing psychosocial intervention paradigms are not designed to help metavivors navigate the emotional turbulence of living while dying, we created LiveWell, an 8- session adapted Dialectical Behavioral Therapy Skills Training protocol that teaches patients transdiagnostic, easy-to-use skills (e.g., mindfulness, distress tolerance, emotion regulation, interpersonal effectiveness) to enable them live as well as possible, with metastatic lung cancer. The proposed research enhances the health and quality of life of the growing number of lung cancer metavivors by addressing their unmet emotional needs and offers a promising psychosocial intervention paradigm for other groups of metavivors and patients living with chronic illness.